Puerto Rico Center for Microbiome Sciences

Project Summary
The overall goal of the COBRE Puerto Rico Center for Microbiome Sciences (PR-CMS) is to accelerate
and expand research capacity at the University of Puerto Rico Medical Sciences Campus (UPR-MSC).
The PR-CMS plans to become an innovative platform designed to maximize research synergy in the
microbiome field and bring innovation in data sciences to the region. By leveraging the available expertise
and facilities, the COBRE PR-CMS will expand the research and learning opportunities of the new
frontiers of microbiome research. This COBRE Phase I Center will bring unique support for data
production and sequence analyses at the University of Puerto Rico, becoming the first facility of its kind
in the region. The goals of the Center include 1) Fostering the development of meritorious junior
investigators into competitive researchers working on projects with broad biomedical significance, 2)
Managing programmatic activities and providing professional development support and tools to promote
interdisciplinary collaborations at the basic and translational levels, and 3) Establishing a Microbiome
Research Core that includes instrumentation and technical support required to conduct state-of-the-art
research. The CMS will be supported by three cores, an Administrative Core for infrastructure
enhancement and faculty development activities, a new Microbiome Research Core with expertise in
data production and analyses, and a Research Support Core, which will sustain the research of three
junior Research Project Leaders (RPLs) working to expand their scientific studies. The three Research
Projects (RPs) are mentored by productive senior faculty who are committed to their success. These
projects address important biomedical problems in the areas of mental health (RP1), seizure disorders
(RP2), and oral cancer (RP3). Despite being diverse in scope, they are unified by a focus on microbiome-
driven processes. The COBRE PR-CMS will establish important partnerships with existing core facilities
and become part of the national “Microbiome Centers Consortium”, a network across the US that is
accelerating the understanding of microbiomes by sharing resources, promoting data standards, and
fostering ethical research practices. The COBRE PR-CMS will be the first core facility of its kind in the
Caribbean region. The Center will hence support a dynamic research community, enabling the training
of a new generation of scientists able to address fundamental questions about the microbiome.

Public health relevance
Project Narrative The COBRE Puerto Rico Center for Microbiome Sciences (PR-CMS) will accelerate and expand biomedical research at the University of Puerto Rico by focusing on the field of microbiome sciences. The PR-CMS will advance cutting-edge microbiome research and create an infrastructure to develop early career faculty, sustaining the continuous maturation of the research enterprise in Puerto Rico.